Understanding Oral Anticoagulation Use and Success Among Patients with Psychiatric Multimorbidity in Atrial Fibrillation

Project Summary
My long-term career goal is to become an independent pharmacist researcher with expertise in psychiatric
multimorbidity research in cardiovascular disease. Through my research program I aim to identify factors that
influence the health and medication taking behaviors of older adults with psychiatric multimorbidity using “real
world” observational data and direct patient and stakeholder engagement. I have clinical (PharmD) and graduate
(PhD) training in pharmacy and I am an assistant professor at Northeastern University in the Department of
Pharmacy and Health Systems Sciences. Training facilitated by this K01 award will help me achieve my long-
term career goal by building on my clinical and technical skills as a pharmacist and researcher and providing me
with the protected time necessary to expand my expertise in longitudinal data analysis, mixed methods and
patient-centered research in cardiovascular disease and multimorbidity. I have assembled an outstanding,
committed, and interdisciplinary team of nationally renowned experts in fields relevant to the proposed research
and my long-term goals. My training plan complements my prior training and experience and incorporates
interaction with mentors, formal coursework, hands-on training, workshops, conferences and research activities.
Using a mixed methods design, my proposal seeks to build and expand on my preliminary work completed in
partnership with the ongoing NHLBI funded study, Systematic Assessment of Geriatric Elements in Atrial
Fibrillation (SAGE-AF). I will leverage observational data, currently being collected in SAGE-AF, to evaluate the
longitudinal impact of psychiatric multimorbidity (i.e., dyads and the triad of depression, anxiety and cognitive
impairment) on oral anticoagulant (OAC) use and outcomes in patients with atrial fibrillation (AF). I will examine
relationships between psychiatric multimorbidity and clinical outcomes such as bleeding and medication
adherence. I will also examine relationships between psychiatric multimorbidity and patient reported outcomes
that are not readily available in the medical record but are increasingly important to patients, their families and
clinicians such as patient satisfaction and health-related quality of life. Then, I will conduct focus groups of SAGE-
AF participants (92% report willingness to continue in SAGE-AF) and stakeholders to understand protective
factors that influence anticoagulation success among patients with psychiatric multimorbidity, including factors
that are not evaluated in the SAGE-AF data. The specific aims are to: 1) Examine the relationship between
psychiatric multimorbidity and OAC prescribing in AF; 2) Among OAC users, examine longitudinal associations
between psychiatric multimorbidity and OAC success indicators and patient reported outcomes over 2 years;
and 3) Conduct 6-8 qualitative focus groups including SAGE-AF participants, their caregivers and their clinicians,
to identify factors that influence OAC success. This proposal aligns with NHLBI’s overarching objective 3 by
investigating factors that account for differences in health among populations and has high potential to identify
factors that can be useful targets for patient-centered interventions.

Public health relevance
Project Narrative Limited evidence suggests that depression, anxiety and cognitive impairment often cluster in older adults with atrial fibrillation (i.e., psychiatric multimorbidity) and may have a multiplicative negative effect on health outcomes such as poorer oral anticoagulant medication adherence and health-related quality of life. This K01 project will explore: (1) the prevalence of specific dyad and triad combinations of psychiatric multimorbidity; (2) how psychiatric multimorbidity affects oral anticoagulant use and outcomes; and (3) factors that influence successful anticoagulation in patients with psychiatric multimorbidity. Understanding the impact of psychiatric multimorbidity on oral anticoagulant use and success and understanding factors that influence success will help identify useful targets for intervention to ultimately improve the health of atrial fibrillation patients with psychiatric multimorbidity.